Signal Generation and Processing in the Retinohypothalamic Pathway

PROJECT SUMMARY
This proposal concerns the broad question of how relevant information is extracted from the environment and
formatted according to animal needs. We focus on the process by which light synchronizes the circadian clock
with the solar day and thus sets appropriate patterns of physiology and gene expression throughout the body.
In mammals, this process requires neurons in the eye that sense light directly using a molecule called
melanopsin and indirectly by receiving input from retinal circuitry. These melanopsin neurons wire into the
principal circadian clock—the suprachiasmatic nucleus of the brain—via the retinohypothalamic pathway. We
have developed new methods of investigating this pathway ex vivo under naturalistic conditions. First is a
means of identifying melanopsin neurons that maintains their maximum photosensitivity (both intrinsic and
extrinsic). Second is an experimental preparation in which the retina and suprachiasmatic nucleus retain
functional connectivity. Using these methods, we will investigate how photic information arises in the retina and
acutely drives neurons of the suprachiasmatic nucleus. We will focus on how this process produces a
representation of the overall light intensity, which reflects the sun’s position in the sky and is used by the clock
to maintain alignment with the day/night cycle. Specifically, we will ask how retinal and suprachiasmatic
circuitry smooth away rapid fluctuations in light intensity, which tend to be uninformative for the clock (being
caused, for example, by a passing cloud or flash of lightning). We expect that this work will provide knowledge
of how neural processing is tailored to specific tasks and how environmental cues interact with internal states
according to animal needs.

Public health relevance
PROJECT NARRATIVE Light acts through the retina to regulate the circadian clock. Circadian dysregulation is implicated in cancer, cardiovascular disease, metabolic disorder, and mental illness. We propose to define the normal function of retinal neurons and their signaling to the principal circadian clock, which is located in the brain, to gain insight into the basis of circadian regulation and dysregulation.